Microneedle patch for the stabilization and dose-sparing delivery of rabies vaccine

PROJECT ABSTRACT
Approximately 60,000 human deaths occur each year from rabies. Although rabies vaccines have been
developed for pre- and post-exposure prophylaxis (PEP), access to vaccination has limited prevention and
treatment of the life-threating infection. Developing countries and remote communities are disproportionally
susceptible, compounded by high costs and complex regimens (multiple boosters) associated with treatment.
Further, rabies and many other vaccines require maintenance of cold chain up to the point of administration.
Vaccine delivery intradermally using a dissolvable microneedle approach could result in key benefits such a
more rapid immune response at a reduced administered dose, and improved antigen stability would be
significant. Luna Labs therefore proposes to advance development of a resorbable microneedle patch for
intradermal administration of human rabies vaccine. The proposed technology builds upon existing work at Luna
Labs, and the novel excipient will support the room-temperature stabilization of the vaccine prior to controlled
resorption and antigen release. Antigen loading will be optimized, and the approach will enable consistent,
reliable immunization with minimal training. The Phase I effort will demonstrate feasibility for microneedle delivery
of the stabilized human rabies vaccine in an in vivo study of antigenicity, and future work will expand study of
vaccine stability and preclinical safety and efficacy.

Public health relevance
PROJECT NARRATIVE The need for most vaccines to be maintained at regulated (4, -20, or -80 °C) temperatures up to the point of administration has been a significant barrier to wide-scale administration of rabies and other vaccines. We therefore propose the development of a microneedle patch for the stabilization and intradermal delivery of human rabies vaccine. The approach offers a reliable mechanism of vaccine delivery that would be significant for improved accessibility to immunization against the life-threatening infection.